Itch, proteases and protease-activated receptors

DESCRIPTION (provided by applicant): Pruritus is a major symptom of dermatologic and internal conditions. It can be difficult to treat, as few specific inhibitors of itch are available and the mechanism that triggers the sensation of itch is not clear. Although most experimental studies of itch use histamine as the pruritic stimulus, most cases of clinical pruritus are considered to be histamine independent. The discovery of natural compounds that evoke itch without releasing histamine might facilitate the search for endogenous mediators and receptors distinct from histamine. Spicules of the plant Mucuna pruriens (cowhage) when lodged in the epidermis produce moderate to severe itching that is independent of histamine. We have determined that the active compound in cowhage is mucunain, a cysteine protease. We have also determined that mucunain is a ligand for human protease-activated receptors 2 and 4. We hypothesized that human cysteine proteases might share homology with mucunain, activate these same receptors, and function as endogenous mediators of pruritus. We provide data that this is the case with certain cathepsins, notably Cathepsin S. Cathepsins have been implicated in many processes but have not previously been considered signaling molecules. The experiments proposed in Aim 1 are designed to decipher the mechanism by which cysteine proteases activate their cognate receptors. Experiments proposed in Aim 2 with receptor knockout mice will determine if such receptors are indeed necessary for the nociceptive effects of cathepsin S. The promoter region of cathepsin S contains STAT binding sites leading us to hypothesize that the critical pruritus-associated cytokine IL-31 activates its receptor leading to the induction of cathepsin S expression. This hypothesis will be tested in Aim 3. The hypotheses and experiments presented here link together three molecules that have previously been associated independently with itch and inflammation: PARs, cathepsins and IL-31.

Public health relevance
PUBLIC HEALTH RELEVANCE: Itching is a major symptom of dermatologic and many internal conditions and is difficult to treat. The goal of this project is to examine how certain proteins, called cysteine proteases, not previously associated with itching, appear to turn on specific receptors and cause itching. The results of this project may lead to the development of new drugs to treat itch. Narrative: Itching is a major symptom of dermatologic and many internal conditions and is difficult to treat. The goal of this project is to examine how certain proteins, called cysteine proteases, not previously associated with itching, appear to turn on specific receptors and cause itching. The results of this project may lead to the development of new drugs to treat itch. __SpecificAimsTextDelimiter__ Specific Aims Itching is a major symptom of dermatologic conditions and of systemic conditions that are manifest in the skin (Stander et al. 2007). It can cause great distress and lead to secondary infections, scarring and disfigurement (Desai et al. 2008). Recent investigations are leading to an improved understanding of the basic mechanisms underlying peripheral and central pathways of itch. This application is directed to a new hypothesis regarding peripheral pathways of itch: We suggest that cathepsin S is an endogenous mediator that evokes itch via stimulation of protease-activated receptors two and possibly four (PAR2 and PAR4). We hypothesize further that interleukin 31 and IFN-, critical cytokines but indirect mediators of itch, induce the expression of cathepsin S to evoke the sensation of itch. Broader implications of interactions between cathepsins and PARs in inflammatory conditions, from asthma and arthritis to atherosclerosis are noted. There are two peripheral pathways that are primarily responsible for mediating the sensation of itch (Namer et al. 2008). These are the histamine-dependent and histamine-independent pathways. Since histamine itch is associated with urticaria, and most itches neither respond effectively to anti-histamines nor feature urticaria, most peripheral itches are histamine-independent (Ikoma et al. 2006, Davidson et al. 2007). The discovery of natural non-histaminergic compounds that elicit itch would direct efforts to identify novel endogenous ligands and receptors that mediate pruritus. In this regard, a potent non-histamine stimulus of itch is evoked by the spicules that cover the pods of the plant Mucuna pruriens (cowhage). We determined that the active compound in cowhage is mucunain, a cysteine protease (Reddy et al. 2008). We also found that mucunain is a ligand for human protease-activated receptors 2 and 4. This led us to consider that homologous cysteine proteases exist in humans that act as endogenous ligands for PAR2 and PAR4 to evoke pruritus. Preliminary studies to test this hypothesis identified cathepsin S and cathepsin K as mucunain homologues capable of evoking itch and activating PAR2 and PAR4. Prior known roles of cathepsins S and K include proteolytic processing involving antigen presentation, degradation of elastin, bone resorption and inflammation but a role for cathepsins in signaling in general or itch in particular had not been considered. The Aims of this proposal test hypotheses regarding the relationships between cathepsin S, PARs and IL-31. Specific Aim 1: To determine the biochemical mechanism by which mucunain and cathepsin S activate PARs. Specific Aim 2: a) To determine if cathepsin S induced scratching requires PAR2 receptors. b) to determine if IL-31 induced scratching is dependent upon cathepsin S. Specific Aim 3: a) To determine if IL-31 induces the expression of cathepsin S in human keratinocytes and 3-dimensional human skin equivalents. b) To determine if cathepsin S is present in pruritic dermatoses associated with IL-31. The goals of this proposal are to evaluate the hypothesis that cathepsins and PARs constitute ligand - receptor pairs relevant to itch. Addressing these Aims may provide the impetus to test recently developed inhibitors of cathepsin S as a new therapy for the treatment of pruritus. Relieving itch would be a breakthrough in decreasing the burden of skin disease. We suggest that a teleologic explanation for itch is that PARs function as innate sensors and detect the ubiquitous cysteine proteases produced in Nature. Abbreviations used commonly in this proposal: AD: atopic dermatitis, Cat S: cathepsin S, Cat K: cathepsin K, CP: cysteine protease, CTCL: cutaneous T-cell lymphoma, JAK: Janus kinases, DRG: dorsal route ganglia, GPCR: G-protein coupled receptor, immunohistochemistry (IHC), KC: keratinocyte, normal human keratinocytes: NHEKs, PAR2 and PAR4: protease-activated receptors 2 and 4 respectively, SP: serine protease, STAT: signal transducers and activators of transcription